CHANGING THE NATURAL HISTORY OF TYPE 2 DIABETES – “CHANGE” STUDY

We will test the hypothesis that the typical worsening of hyperglycemia in type 2 diabetes (DM) will
be reduced by keeping glucose normal compared to usual care.
Progression of hyperglycemia is mediated by loss of β-cell function, which will be mitigated by
normalizing glucose, reducing the “excitotoxicity” leading to β-cell dedifferentiation and apoptosis. In multiple
studies, when lifestyle change or Rx reduced progression from PreDM to DM, there was no “catch-up” after the
interventions ended – cumulative DM remained less than in controls, consistent with a change in the natural
history. Reaching normal glucose is beneficial regardless of the mechanism: in the Diabetes Prevention
Program (DPP), PreDM subjects who achieved normal glucose levels only once, had 56% less DM in the DPP
Outcomes Study (DPPOS) – similar in lifestyle change, metformin, and control groups.
This study will be novel, but the approach will be easy to translate into practice: 1) Aim for normal
glucose, instead of testing an Rx or mechanisms. 2) Start early in the natural history, allowing use of Rx
with a very low risk of hypoglycemia. 3) Target early DM instead of PreDM, using Rx already FDA approved
for DM. 4) Use accelerated stepped intensification of Rx to keep glucose normal with intensive Rx.
Aims: assess effect size, β-cell function, retinopathy, nephropathy, CGM, and cost-effectiveness.
Methods: We will study 126 adults, 1/3 each in 3 groups of early DM (A1c 6.0-6.9%, no Rx; A1c 6.0-6.9%
on metformin; A1c 7.0-7.4%, on metformin). After a 2-week run-in [to establish tolerance to metformin (if not
on it already), and adherence to self monitoring of blood glucose (SMBG)], all subjects will have lifestyle
change support; HbA1c and continuous glucose monitoring (CGM) every 3 months; and be randomized 1:1, to
intensive Rx: adding Rx if SMBG levels are > goal (<100 mg/dl premeal, <130 postmeal, total 7 tests/week) at
least 3x/week for 2 weeks in a row after ≥4 weeks of maximum tolerated dosage (MTD) of each Rx: metformin
(if not on it at baseline) + TZD pioglitazone + GLP-1 RA semaglutide + SGLT2 empagliflozin + glargine U300
insulin; or control Rx: in the same order, based on A1c every 3 months: metformin if ≥7.0%, other Rx if ≥7.5%.
Outcomes: Over 2.5 years, plus a 3-month washout, we will quantitate i) effect size – differences in
HbA1c with intensive Rx vs. controls; and (ii) β-cell function, primarily using 3-hour OGTTs with modeling as
in RISE, since trends with intensive Rx vs. controls post-washout may indicate whether β-cell function is likely
to be sustained. We will also explore (iii) retinopathy (by blinded grading of fundus photos); (iv) nephropathy
(microalbuminuria and eGFR); (v) whether 14 days of CGM could be substituted for SMBG in identifying the
need to add another Rx (since CGM might be easier to use in primary care), and (vi) cost-effectiveness.
Impact: A positive study will lead to a change in medical practice, since early diagnosis and normalizing
glucose should produce longterm benefits, including reduced diabetes complications, mortality, and costs.

Public health relevance
Diabetes is a disorder of high blood glucose, that tends to get worse; over time, patients need more and more drugs. This pattern is caused by overwork of the body's insulin-producing β-cells, because patients' glucose levels are typically above normal; if we kept glucose levels normal – reducing β-cell work – we might be able to keep the disease from getting worse. Our trial is aimed to show that adjusting the drugs to keep glucose levels normal, can help to preserve β-cell function compared to usual diabetes care, possibly reduce the tendency to develop the eye and kidney complications of diabetes, and might also be more cost-effective than usual care.